CDK7 inhibitors as a new strategy to overcome treatment resistance in ER+ metastatic breast cancer

Project Abstract
The majority of breast cancers are estrogen receptor positive (ER+) and ER+ breast cancer is the leading
cause of breast cancer mortality. Despite the widespread adoption of adjuvant endocrine therapy for patients
with ER+ breast cancer, almost all patients with ER+ metastatic disease will eventually develop resistance to
endocrine treatments. A number of mechanisms of endocrine resistance were proposed but for the most these
were predominantly based on preclinical evidence. Recently, our group and a number of other groups identified
estrogen receptor (ER) ligand-binding domain (LBD) mutations as the most prevalent genomic mechanism of
endocrine resistance identified in patients with ER+ metastatic breast cancer. These mutations are associated
with decreased overall survival in ER+ metastatic breast cancer. The addition of CDK4/6 inhibitors (CDK4/6i) to
endocrine treatment has been shown to improve progression free survival in patients with metastatic ER+ breast
cancer, but have not been shown to improve overall survival. Despite this advance, patients with metastatic
disease invariably develop resistance to this combined therapy, exhaust other chemotherapy options, and
ultimately die of their disease. There is an urgent need to develop new therapeutic strategies to overcome
resistance to endocrine treatment and CDK4/6i.
Our preliminary data suggests that selective inhibition of CDK7 can overcome resistance to endocrine
resistance driven by the ER mutations and resistance to CDK4/6i. CDK7 has key roles in transcriptional and cell
cycle regulation. SY1365 is a selective CDK7 inhibitor that is in early stages of clinical development for cancer
treatment. This study is designed to comprehensively study the activity of SY1365 as a single agent and in
combination with fulvestrant for the treatment of ER mutant endocrine resistant and CDK4/6i resistant ER+
metastatic breast cancer. We will investigate the mechanisms by which CDK7 inhibition exerts anti-tumor activity
and overcomes resistance to endocrine treatment driven by the ER mutations and resistance to CDK4/6i.
Because CDK7 phosphorylates RNA polymerase II and also functions as a CDK-activating kinase, we will test
the effects of SY1365 on nascent RNA and mRNA transcripts, CDK2 phosphorylation and cell cycle progression
in ER+ breast cancer models. We will study mechanisms of resistance to CDK7 inhibition and synthetic lethal
vulnerabilities in the presence of SY1365. Lastly, we will test the activity of SY1365 in endocrine resistant and
CDK4/6i resistant PDX models derived from metastatic tumors from patients with ER+ disease.
Results from this study have the potential to lead to a clinical trial testing the efficacy and on target activity
of a new class of drugs, selective CDK7 inhibitors, for the treatment of endocrine and CDK4/6i resistant ER+
metastatic breast cancer. These results could lead to a new therapeutic strategy to improve outcomes in a
substantial number of patients with metastatic ER+ breast cancer.

Public health relevance
Project Narrative Metastatic estrogen receptor positive (ER+) breast cancer is the leading cause of breast cancer mortality. We will investigate the role of CDK7 inhibitors as a therapeutic strategy in metastatic ER+ breast cancer. Results from this study could lead to a new paradigm in the treatment of patients with metastatic ER+ breast cancer.